Regulation of neuronal calcium transfer between mitochondria and lysosomes in health and neurodegeneration.

PROJECT SUMMARY
Inter-organelle contact sites, which form dynamically between two different organelles and represent sites
for metabolite transfer, have become increasingly appreciated as essential regulators of cellular homeostasis.
Recently, our lab identified novel membrane contact sites between mitochondria and lysosomes in non-neuronal
cells, which allow for bidirectional regulation of lysosomal and mitochondrial dynamics including mitochondrial
fission and highlight a new pathway through which the two organelles can interact. Interestingly, both
mitochondria and lysosomes are implicated in cellular calcium homeostasis, and dysfunction in both organelles
has been linked to neurodegenerative disease. Calcium homeostasis is particularly important in neurons, where
in addition to regulating functions such as ATP production and cellular signaling, calcium also modulates
excitability and neurotransmitter release, suggesting that a more tightly-regulated mechanism of calcium transfer
between organelles could be beneficial in neuronal cell types. Importantly, our preliminary data in non-neuronal
cells suggest that activation of lysosomal calcium release increases mitochondrial calcium and that disruption of
mitochondria-lysosome contact sites alters these calcium dynamics. Given these data, elucidating if and how
mitochondria-lysosome contact sites transfer calcium in neurons will be critical for understanding how calcium
dyshomeostasis may contribute to pathologic processes such as neurodegeneration. In this project, I propose
to investigate the mechanisms and regulation of calcium dynamics at mitochondria-lysosome contact sites and
their subsequent dysfunction in neurodegenerative disease using advanced microscopy techniques including
super-resolution live cell microscopy and calcium imaging in long-term cultures of human induced pluripotent
stem cell (iPSC)-derived neurons. In Aim 1, I will investigate the mechanisms of bidirectional calcium transfer at
mitochondria-lysosome contact sites using human-derived cortical neurons. Additionally, as several lysosomal
calcium transporters, including ATP13A2, have been implicated in neurodegenerative diseases, dysregulation
of calcium dynamics between the two organelles may represent a potential pathway driving neurodegeneration.
In Aim 2, I will investigate how disease-linked loss-of-function mutations in ATP13A2, which cause Kufor-Rakeb
syndrome, an atypical form of parkinsonism with dementia, alter mitochondria-lysosome contact site dynamics
and calcium homeostasis, and further contribute to downstream dysfunction in both organelles in patient-derived
cortical and midbrain dopaminergic neurons. Together, the proposed research and training plan will offer
important opportunities to not only acquire new experimental techniques in advanced imaging and human
disease modeling to foster my development as a physician-scientist, but to also gain insight into the molecular
mechanisms underlying neurodegeneration. A better understanding of these neuronal pathways will facilitate the
identification of novel therapeutic targets, which may ultimately improve patient outcomes.

Public health relevance
PROJECT NARRATIVE Mitochondrial and lysosomal dysfunction are implicated in various neurodegenerative diseases, but the precise molecular mechanisms driving neurodegeneration and their interplay with calcium dyshomeostasis are still not completely understood. The proposed research will investigate the role of recently-discovered mitochondria- lysosome contacts in regulating calcium dynamics between mitochondria and lysosomes in healthy and diseased human neurons. Understanding how mitochondria-lysosome contact sites modulate neuronal calcium homeostasis will thus provide novel insights into how these contact sites contribute to cellular dysfunction in neurodegeneration.